Exploiting markers of genomic instability in high-risk pre-invasive ovarian cancer

ABSTRACT
High grade serous ovarian cancer (HGSC) is the most lethal gynecologic malignancy. Patients with increased
risk of ovarian cancer due to inherited syndromes–most notably carriers of pathogenic variants of
BRCA1/BRCA2–are recommended to undergo prophylactic risk reducing salpingo-oophorectomies (RRSO)
because there is no effective ovarian cancer surveillance. Despite undergoing surgical removal of ovaries and
fallopian tubes, 10-20% of patients will experience primary peritoneal cancer, an ovarian cancer related
malignancy. As such there is a dire need to understand the early events in HGSC development to improve
therapeutic decisions for high-risk patients. Importantly, a recent study found that the presence of serous tubal
intraepithelial carcinoma (STIC) at RRSO was associated with 10.5% risk of developing primary peritoneal
carcinoma (PPC) compared with a 0.3% risk in patients with normal fallopian tube histology at the time of surgery.
HGSC is characterized by high rates of genomic instability arising from ongoing chromosome missegregation
due to defective mitotic machinery or errors in DNA repair and replication. We hypothesize that genomic
instability is a critical event in the transition between STIC and invasive HGSC, endowing cancer cells
with karyotypic diversity needed for invasion and immune evasion. We will investigate this hypothesis by
1) Quantifying cGAS, a marker for cytosolic DNA, in fixed patient samples as a biomarker for chromosomal
instability. 2) Interrogating disruption of the local immune microenvironment in STIC and HGSC as a function of
aneuploidy 3) Quantifying rates of aneuploidy in single cells as a marker for early transformation and 4)
Integrating the molecular and imaging markers to identify and validate features associated with invasive STICs.
An understanding of the processes that mediate the transition between non-invasive STIC to invasive HGSC will
lay the groundwork for discovery of early detection markers. Moreover, as genetic testing increases and identifies
high-risk patients for RRSOs and even normal risk patients more often undergo opportunistic salpingectomies,
it is likely we will identify patients with STICs. This project will allow us to focus on patients with evidence of
genomically unstable STICs who may be at a greater risk to develop subsequent PPC and thus may require
closer surveillance and/or adjuvant chemotherapy. Moreover, the FFPE tolerant scWGS technology developed
as part of this proposal will allow us to interrogate the timing of genomic instability and clonal relationships
between STIC and HGSC. This will fundamentally enhance our understanding of the events in ovarian cancer
initiation and lays the foundation to further improve early detection of HGSC in patients.

Public health relevance
PROJECT NARRATIVE Ovarian cancer is a lethal malignancy that often begins in the fallopian tubes with serous tubal intraepithelial carcinoma (STIC) and recent work has demonstrated that the presence of STICs is associated with a high risk for primary peritoneal cancer, an ovarian cancer related malignancy. Currently there are few biomarkers for STIC or early ovarian cancer, nor are there consensus guidelines for how to best care for patients with STIC, and we therefore propose to characterize cellular and molecular features of healthy fallopian tubes, STIC and invasive cancer. Our goal is to identify markers in STICs that are indicative of high risk for invasion and possible primary peritoneal cancer so these patients can be selected to undergo more aggressive surveillance or treatment.